Computational Technology for Single-Cell Functional Genomics

Abstract
Genome-wide association studies have unveiled millions of single nucleotide polymorphisms (SNPs)
associated with common diseases. Yet, the functional mechanism of most SNPs in these diseases still needs
to be discovered. My recent studies suggested that hundreds of thousands of SNPs strongly associate with
ligand gene expression in the GTEx dataset, suggesting the impacts of these SNPs on many cell types in a
tissue niche via ligand-receptor interactions. However, the lack of robust technology that adequately considers
the context of tissue niches constrains the systematic characterization of SNP functions in health and
diseases. This project, empowered by functional genomics approaches, aims to address this challenge. I will
develop robust computational technologies for single-cell functional genomics, allowing comprehensive
identification of SNPs regulating tissue niches and elucidating their regulatory roles in health and diseases. In
Aim 1 (K99 phase), I will develop computational frameworks with deep learning models to decode the
epigenetics response of a cell to intercellular communications with other cells. The performance of my
algorithm will be systematically validated by RNA-seq and ATAC-seq profiles under control and ligand
treatment conditions. In Aim 2 (K99 and R00 phase), I will develop robust statistical methods to identify the
impact of SNPs on the tissue niches via ligand-receptor communications. The effects of SNPs on ligand
expression will be elucidated by integrating the SNPs with genome-wide transcription factor binding sites and
chromatin status. In Aim 3 (R00 phase), I will employ robust computational technologies to identify clinically
relevant SNPs that regulate tissue niches via intercellular ligand-receptor communications. I will also validate
the SNP functions by prime editing, focusing on endothelial cells and adipocytes in adipose tissue, which are
tightly associated with many diseases, including obesity, diabetes and complications, and cardiovascular
diseases. This study will lay a solid foundation for future research as an independent scientist focusing on
genetic diseases. My extensive experience in epigenetics, intercellular communication modeling, and single-
cell data analysis positions me uniquely to execute this proposal. The project will be supervised by an
interdisciplinary team, including Dr. Kaifu Chen for bioinformatics, Dr. Yu-Hua Tseng for metabolic diseases,
and five collaborators with expertise in deep learning, big data integration, statistical genetics, and prime
editing. The training will also include professional skills such as scientific writing, communication, and
mentoring. The outstanding research environment at Boston Children’s Hospital and Harvard Medical School
will further enhance the execution of the proposed study. Completing this training and proposal during the K99
phase will well prepare me for a future role as an independent researcher in translational genetics and
genomics research, ensuring a seamless transition into the R00 phase.

Public health relevance
Narrative Genetic variants play a pivotal role in determining individual susceptibility to various diseases. This project aims to elucidate the intricate roles of single nucleotide polymorphisms (SNPs) in health and human diseases, specifically their influence on cell-cell communication within tissue niches. By providing a deeper understanding of these genetic regulators using functional genomics and computation approaches, the research will potentially identify critical therapeutic targets of ligand-receptor pairs for future drug discovery for genetic diseases.